Integration and Evaluation of the cMHQ, a Novel Transdiagnostic Mental Assessment in Clinical Pediatric Practice

ABSTRACT
In this SBIR Phase II we will design, integrate, and evaluate implementation protocols in both primary care
and behavioral health for the pediatric adaptation of the clinical Mental Health Quotient (cMHQ), a
comprehensive transdiagnostic mental health assessment tool developed in Phase I, along with a short
screener called the MHQ-10. This work will be done in collaboration with the UC San Diego ImplementatioN
Science and Team Effectiveness in Practice (IN STEP) Children’s Mental Health Research P50 ALACRITY
Center and Rady Children’s Hospital San Diego (RCHSD), and will test the feasibility, acceptability, and
effectiveness across two Rady pediatric primary care clinics and one mental health referral hub. The
majority of instruments presently in use have numerous challenges including a lack of insight into the
individual’s specific symptom profile, particularly missing many of the emerging symptoms in adolescents,
as well as lack of insight into positive aspects of the patient, their lifestyle, traumas, adversities and other
factors that can give the clinician a whole person view. The pediatric MHQ-10 is a first line screener to be
offered in primary care that overcomes limitations of current short screeners by incorporating emerging
symptoms in adolescents as well as positive capacities to position individuals on a mental wellbeing scale
that enables more precise triage. The pediatric cMHQ will be offered to those recommended for
intervention by the MHQ-10 or those presenting for behavioral health challenges and overcomes the many
limitations in the current landscape. Through a single compact assessment, it captures a comprehensive
transdiagnostic symptom profile mapping to ten disorders, positive/protective life factors, lifestyle, life
traumas and adversities to generate a vetted clinician report that includes a score of their aggregate mental
wellbeing that can track their preclinical trajectory and provide guidance to the clinician. However, beyond
the design of the assessment itself, the success of any new assessment within a hospital or clinic depends
crucially on how it is embedded in the workflow and the consequent patient and clinician experience. This
involves key criteria such as when and how patients are presented the assessment, how they are
encouraged to complete the assessments, when and how doctors are presented the reports, and how they
are guided to use the reports during the appointment. In this Phase II SBIR we will use an innovative,
participatory implementation research method of co-design (brainwriting premortem) to develop a powerful
workflow for integration of the pediatric MHQ suite within primary care and behavioral healthcare at RCHSD.
This workflow will be designed to flexibly fit within a range of electronic health record platforms although it
will be specifically implemented for Epic which is used at Rady. This will be followed by a multi-dimensional
evaluation of implementation that will form the basis for enabling widespread adoption and a transformative
paradigm for integrated mental health care.

Public health relevance
NARRATIVE Sapien Health has developed the pediatric Mental Health Quotient – 10 (MHQ-10) mental health triage tool and the Clinical Mental Health Quotient (cMHQ), which, through a single compact assessment, captures a comprehensive symptom profile, positive/protective life factors, lifestyle, life traumas and adversities to generate a vetted clinician report that includes a score of their aggregate mental wellbeing and guidance to the clinician that enhance opportunities for preventative care and effective choice of treatment. Successful implementation of any new assessment within a hospital or clinic depends crucially on how it is embedded in the workflow and the consequent patient and clinician experience such as when and how patients are presented the assessment, how they are encouraged to complete the assessments, when and how doctors are presented the reports, and how they are guided to use the reports during the appointment. In this Phase II SBIR we will use an innovative, participatory implementation research method of co-design (brainwriting premortem) to develop a powerful workflow for integration of the pediatric MHQ suite within primary care and behavioral healthcare at Rady Children’s Hospital San Diego and evaluate its feasibility, acceptability and perceived patient and clinician benefits.